The SoundMind Smart Amplifier: An affordable, accessible, user-friendly hearing solution for persons with memory concerns and their family caregivers

Abstract
Hearing loss and memory concerns are prevalent health issues among American older adults,
significantly affecting their quality of life. Two-thirds of Americans aged 70 and older experience audiometric
hearing loss and one-third suffer from clinically significant cognitive impairment, including dementia. When
these conditions co-occur, their effects on communication and social engagement are compounded, leading to
increased isolation and decreased quality of life. Hearing amplification technology can mitigate these effects
by enhancing speech audibility and reducing cognitive listening effort, thereby improving communication and
social engagement. Despite these benefits, only 30% of people with memory concerns (PWMC) use hearing
aids due to barriers such as cost, access, and the complexity of current hearing aid technology.
Existing hearing technology fails to meet the specific needs of PWMC and their caregivers. The recent
introduction of over-the-counter (OTC) hearing aids by the FDA addresses some cost and access issues, but
leaves other issues unaddressed. Current hearing aids, whether OTC or prescription, often involve complex
handling and programming, which PWMC find challenging. This increases dependence on caregivers, who
already face significant burdens. An alternative option is personal sound amplification products (PSAPs) in the
form of ear-level amplifiers and larger “pocketalkers” Many of these devices aim to address usability concerns
but lack the evidence-based audio profiles and advanced connectivity features contained in hearing aids.
Importantly, to our knowledge, no available hearing device integrates evidence-based sound therapies that
have been shown to benefit PWMC, nor do they include a caregiver-facing mobile application specifically
designed for caregivers of PWMC.
To address these gaps, we propose developing the SoundMind assistive hearing system, a smart
amplifier specifically designed to meet the needs of PWMC and their family caregivers. This system will feature
an intuitive design with larger, easy-to-handle parts and uses familiar consumer headphones to promote
comfort and ensure ease of use. It will include a caregiver-enabled smartphone application for remote
assistance and incorporate customized auditory reminders and music therapy, both of which have been shown
to benefit PWMC, but which have not yet been incorporated into hearing amplification. The SoundMind system
aims to improve the quality of life for PWMC by facilitating easier use of hearing technology, thereby promoting
social engagement, cognitive health, and overall well-being while reducing caregiver burden.

Public health relevance
Project Narrative Two-thirds of Americans aged 70 and older have hearing loss, and one-third suffer from clinically significant cognitive impairment, including dementia. When these conditions co-occur, their effects on communication and social engagement are compounded, leading to increased isolation and decreased quality of life. The proposed amplifier will provide a low-cost, accessible, user-friendly assistive hearing technology specifically designed for people with co-occurring memory concerns and hearing difficulty, as well as their family caregivers.